Intensive Combination Approach to Rollback the HIV Epidemic in Nigerian Youth (iCARE) Plus Effectiveness / Implementation Hybrid Study

Project Summary
Nigeria has the 4th highest global burden of HIV and an uncontrolled epidemic. Among youth aged 15-24, HIV
incidence remains high and rates of viral suppression low. The HIV epidemic in Nigeria's youth is highest in
men who have sex with men (MSM) and transgender women (TW). Although external (i.e., non-governmental)
funders support key population-focused centers to increase access to HIV services for MSM and TW, their
reach is limited by dwindling and unsustainable funding. Efforts to improve the capacity of government clinics
to reach and care for young MSM (YMSM) and young TW (YTW) as well as to implement effective, scalable,
youth-specific interventions with enhanced prevention, improved case-finding, and increased ART access and
adherence support for youth living with HIV (YLH) are critical to turn around lagging indicators across the HIV
prevention and care continuum. However, to-date, no interventions have undergone rigorous effectiveness and
implementation research in Nigeria's complex sociocultural milieu. iCARE Nigeria is a successful NICHD-
funded PATC3H research partnership investigating two youth-specific interventions to improve: (1) HIV case-
finding and linkage-to-care among YMSM and YTW, and (2) adherence and viral suppression among largely
vertically-infected YLH on ART. Each intervention combines evidence-based peer navigation and mHealth
strategies adapted to the local context; feasibility and efficacy were shown in a pilot study (UG3). We herein
propose iCARE Plus, to scale out and test effectiveness and implementation outcomes on enhanced versions
of the iCARE interventions within the newly formed PATC3H-IN. The iCARE Plus Clinical Research Center
(CRC) will conduct hybrid effectiveness-implementation trials that will utilize an EPIS (Exploration, Preparation,
Implementation, and Sustainment) framework to contextualize intervention implementation in youth aged 15-24
through new Clinical Research Performance Sites (CRPSs) in HIV “hotspots” across Nigeria's six geopolitically
distinct zones. Our specific aims are: Aim 1 (Preparation): Implementation preparation will be carried out at
selected government clinics in the HIV hotspots, while increasing their capacity and capability to provide
services to YMSM and YTW. Aim 2 (Implementation): Test the effectiveness and implementation outcomes of
enhanced versions of the iCARE interventions on: 1) HIV case-finding, linkage-to-care and PrEP uptake
among YMSM and YTW and 2) viral load suppression in previously unstudied YLH newly-diagnosed and
initiating ART. Aim 3 (Sustainment): Promote sustainment of the iCARE initiative and the implementation
science capacity development goals of PATC3H-IN by developing a sustainability plan, including economic
considerations that leverage ongoing formative research funded by an NICHD supplement, in collaboration
with youth, clinic administrators and health ministries and develop IS capacity, building on our Adolescent HIV
Prevention and Treatment Implementation Science Alliance (AHISA)-funded iTRAIN project.

Public health relevance
Project Narrative Nigeria has the 4th highest global burden of HIV and an uncontrolled epidemic. Youth aged 15-24 have high rates of HIV incidence, while retention in care and viral suppression are both poor. The HIV epidemic in Nigeria's youth is highest in men who have sex with men (MSM) and transgender women (TW). Effective, scalable, youth-specific interventions with enhanced prevention, improved case-finding, and increased ART access and adherence support for youth living with HIV, including YMSM and YTW are critical to turn around lagging indicators across the HIV prevention and care continuum. However, to-date, no interventions have shown efficacy or undergone rigorous effectiveness and implementation research in Nigeria's complex sociocultural milieu.